METHODOLOGY CORE

ABSTRACT – METHODOLOGY CORE
Pediatric rheumatic and non-inflammatory musculoskeletal diseases (PMSKD) affect 8.3 million
Americans under the age of 18 (11%). PMSKD are difficult to diagnose and treat, maintain a
chronic course and interfere with growth, development and quality of life. A precision medicine
approach to PMSKD will help address these problems and is made feasible by increasing
availability of biologic databases, patient phenotyping techniques and statistical tools for
analyzing high-dimensional data. Clinical and Translational Research (CTR) is critically important
for linking advances in basic science with ethical and safe testing in humans, and with the
integration of effective treatments in the practice of medicine. CTR relies on a complex array of
methods, and needs methodologic research to support its progress. In response to RFA-AR-17-
002, issued by the National Institute of Arthritis and Musculoskeletal and Skin Diseases (NIAMS)
to fund Core Centers for Clinical Research, Cincinnati Children's Pediatric musculOskeletal &
RheumaTology Innovation COre center (PORTICO) intends to promote precision medicine-
oriented CTR for PMKSD. The performance, scientific output and patient outcomes of the
PORTICO research base will benefit from an infrastructure that coordinates efforts and upholds
high standards for data integration and sharing, reproducibility of results, and efficient use of
patient data and samples. The PORTICO Methods Core (MC) will provide advanced informatics,
statistical and epidemiological expertise in clinical trial design, and data management technology
and processes to ensure the production of evidence needed by CTR. We will 1) Empower PMSKD
researchers with state-of-the art study design and protocol development, efficient study start-up,
expert advice and resources to support study conduct, statistical analysis and interpretation of
study results; 2) Meet the operational, informatics, and data manipulation needs of PMSKD
researchers by providing state-of-the art resources and technology for data acquisition,
management and utilization; and 3) Promote clinical research and training in PMSKD by
developing, applying and disseminating advanced epidemiologic, biostatistical and informatics
methods. Our expertise, infrastructure, technology, institutional support, and our approach to
promoting the collaboration between methodologists and clinical researchers will accelerate
scientific discovery and understanding of PMSKD. It will bring new treatments to trial, translating
into improved health and wellness for patients and their families.